Neural circuit mechanisms underlying pubertal timing

PROJECT SUMMARY
The pubertal transition marks a significant physiological, hormonal, and social change in animals and occurs at
a very stereotyped timepoint within each species. However, the neural circuit mechanisms underlying the
timing of puberty onset remain unknown. More generally, we know little about how the brain orchestrates long-
timescale postnatal developmental timing, which is crucial for normal behavioral and social development.
Puberty is initiated by the pulsatile release of gonadotropin releasing hormone (GnRH) from hypothalamic
GnRH neurons. However, the causal neural mechanisms and stimuli underlying the developmental activation
of GnRH neurons are poorly understood. Three neuronal populations have been speculated to control GnRH
neuron activation, including RFamide-related peptide (RFRP) neurons, which I hypothesize control the timing
of puberty initiation. Administration of the RFRP peptide is sufficient to delay puberty, and the population of
neurons expressing RFRP decreases in cell number over development. However, RFRP neurons are poorly
characterized, and their role in pubertal timing has not been systematically tested. The overarching goal of this
proposal is to functionally and architecturally characterize this neuronal population and its developmental
plasticity to delineate their role in pubertal timing and, more broadly, how coordinated changes in the brain
mediate development. I propose to use state-of-the-art molecular genetic tools to establish the role of RFRP
neurons in pubertal timing and delineate their molecular and connectomic changes through development.
Fulfillment of my aims will provide the most comprehensive characterization of RFRP neurons to date, focusing
on their role in puberty and using them as a model to understand how neural plasticity underlies postnatal
development. This will lay the groundwork for a better understanding of the regulation of pubertal timing,
providing potential therapeutic targets for pathologies such as precocious puberty and a better understanding
of the most drastic transformation in postnatal development. The goal of my research career is to perform
cutting-edge research to answer fundamental biological questions as a faculty in academia. The proposed
goals will be accomplished in the UCSD laboratories of Dr. Dhananjay Bambah-Mukku – an expert on social
behavior and genetic tools for neural circuit research, Dr. Alexander Kauffman – an expert on the neurobiology
of puberty, and Dr. Edward Callaway – a pioneer of viral tract tracing methods. Together, we have outlined a
comprehensive plan for the acquisition of technical and professional skills that will enable me to accomplish my
scientific and career goals at UCSD, which provides an extraordinary environment with all the resources
needed for my training and career development.

Public health relevance
PROJECT NARRATIVE Puberty is a complex transformation through which changes in physiology, hormones, and sociality emerge, but its neural mechanisms are poorly understood. This project aims to use novel, cutting-edge tools in neural circuit research to uncover cell-type specific mechanisms underlying the neural control of pubertal timing. This will provide critical insights into how the brain broadly controls postnatal developmental timing.